Multi-component INTERLUNG intervention to protect lung health in Nepal

PROJECT SUMMARY
Chronic respiratory diseases (CRDs) remain the third leading cause of death worldwide and their incidence is
increasing. In 2019, it was estimated that 455 million people worldwide live with a CRD such as asthma,
COPD, and chronic bronchitis. CRDs are responsible for 4 million deaths and 103.5 million disability-adjusted
life years lost each year. The development and severity of CRDs is attributed to both environmental exposures
and infectious causes. Individuals who live in densely populated cities in low- and middle-income countries
(LMICs) are disproportionately affected by high levels of ambient particulate matter, indoor exposure to
allergens, dust and tobacco smoke, and a high incidence of viral and bacterial infections. Therefore, to have a
meaningful impact on the incidence and severity of CRDs, and prevent further lung function decline, a multi-
component evidence-based intervention targeting multiple risk factors is needed. We seek to test the
implementation and effectiveness of a tailored multi-component evidence-based intervention following a
community health worker (CHW)-driven chronic care delivery model to protect lung health over a 40-month
period using a Type I hybrid implementation-effectiveness randomized controlled trial in Bhaktapur, Nepal. The
multi-component intervention will consist of: reducing environmental risk factors by targeting tobacco smoking
through CHW-delivered messaging and education on smoking prevention and smoking cessation, and
targeting indoor and ambient air pollution exposures by providing households with HEPA-indoor air purifiers
and vacuum cleaners and encourage masking outdoors with N95 respirators when e-notified about days with
high ambient air pollution; reducing infectious risks through an CHW-led vaccine campaign for annual
influenza, COVID and pneumococcal vaccine in all eligible participants and household members; encouraging
use of surgical masks in indoor public spaces during the peak winter season or at home when there are sick
household contacts; and, improving physiologic health by encouraging physical activity through CHW-
monitored pedometer goals. Aligned with the Consolidated Framework for Implementation Research, we will
first conduct human-centered design workshops with community members and healthcare practitioners to tailor
the multi-component intervention. We will then screen and identify 800 index participants aged ≥ 9 years (with
a pre-bronchodilator FEV1/FVC Z-score ≤ 10th percentile and chronic cough or wheeze (i.e., at-risk
participants). We will enroll index participants and household members and assign half of the households to
the adapted intervention. Controls will be asked to continue usual care practices. We will evaluate the effect of
the intervention on pre-bronchodilator FEV1 Z-score (primary outcome), respiratory symptoms, and evaluate
implementation outcomes. We seek to facilitate scale-up of a multi-component intervention that responds to
the real-world implementation context to protect lung health in Nepal and other LMICs.

Public health relevance
PROJECT NARRATIVE We propose to adapt a multi-component intervention to protect lung health across the lifespan in Bhaktapur, Nepal, by mitigating environmental exposures (tobacco, air pollution, allergens), preventing lower tract respiratory infections (through vaccinations, masking, and hand hygiene) and promoting physical activity. We will then test the adapted INTERLUNG (INTERvening for LUNG health) intervention in a type I hybrid effectiveness-implementation randomized controlled trial against usual care over a period of 40 months in 800 participants aged  9 years with pre-bronchodilator FEV1/FVC in the 10th percentile and a chronic cough or wheeze. The primary outcome is pre-bronchodilator FEV1 at 40 months and secondary outcomes include respiratory symptoms, other spirometry indices, and implementation outcomes (adoption, fidelity, acceptability, adherence, self-efficacy, and delivery).